Enabling IL-2 as an Anti-inflammatory Agent through Local Dose-controlled Endoscopic Delivery

PROJECT SUMMARY
Inflammatory bowel diseases (IBD) affects more than 3 million Americans, and can generally be classified as
Crohn’s disease (2 million) or ulcerative colitis (UC, 1 million). A variety of FDA approved treatments exist for
UC, but up to 25% of IBD patients are medically refractory. Ileal pouch-anal anastomosis (IPAA) surgery is
recommended for these medically refractory UC patients, but due to the invasiveness and the long-term quality
of life impact of IPAA surgery, up to 50% of medically refractory UC patients decline this procedure. Effectively
managing and treating medically refractory UC patients is thus an unmet medical need. Biologic drugs have
been shown to be effective in many UC patients when infused intravenously. The dosage of these anti-
inflammatory biologic drugs are limited by the FDA for considerations of toxicity. For example, strong systemic
suppression of the immune system would significantly increase the risk of both infectious diseases and of
cancer. Consequently, the team hypothesizes that delivering high local concentrations of biologic drugs, while
maintaining low systemic biologic concentrations, would increase the effectiveness of biologics in treating UC.
Pana Bio is developing “living drug factories” inside the patient’s GI tract to treat IBD: drug-device
combinations in which engineered L. reuteri bacteria producing biologic drugs are implanted endoscopically.
The engineered bacteria are encapsulated in a hydrogel biomaterial, and enclosed in a porous cage that is
affixed to the GI tract via an endoscopic clip. The hydrogel is selectively permeable to molecules smaller than
100kD, allowing efficient diffusion of biologic drug products, nutrients, and metabolic waste, but not of bacteria
and viruses. Thus, the hydrogel protects the engineered bacteria from competition by native microbes, and
controls the dosing of the biologic drug by limiting the number of bacteria within a patient’s body. Furthermore,
because the bacteria are implanted locally at or near the disease site, Pana Bio will be able to deliver higher
doses of biologic drugs increasing patient overall response rate while maintaining similar toxicity profiles due to
lowered systemic drug concentrations.
In this Phase 1 SBIR application, the Pana Bio team proposes to demonstrate precise local dose
control of IL-2. IL-2 is a powerful, FDA-approved cytokine drug with an unusual pleiotropic property: IL-2 is
pro-inflammatory at concentrations higher than 1nM, and anti-inflammatory at concentrations between 10pM
and 1nM. In Pana Bio’s solution, biologic drugs such as IL-2 are continuously produced and secreted within
the patient’s GI tract in a dose-controlled manner. Specifically, a strain of L. reuteri bacteria will be genetically
engineered to constitutively produce and secrete IL-2, and the quantity of these bacteria can be controlled via
the volume of hydrogel particles loaded and clipped to the UC disease site. The team will show that the
concentration of IL-2 can be precisely controlled and reproducibly maintained steady state, demonstrating
proof-of-concept for using IL-2 as an anti-inflammatory drug for UC.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel diseases (IBD) affects more than 3 million Americans, and current steroid and biologics treatments are ineffective for roughly 25% of IBD patients who are medically refractory. Pana Bio is developing endoscopically implanted drug-device combinations in which engineered bacteria locally, continuously, and controllably deliver biologic (protein) drugs to the disease site. In this Phase I SBIR proposal, the team will focus on demonstrating precise local dose control of IL-2, a powerful cytokine that is known to be anti-inflammatory at lower concentrations but pro-inflammatory at higher concentrations.